Screen, Treat and Retain People with Primary Meth Use Disorder at MMT Clinics (STAR-OM+)

Project summary
We propose to build upon the STAR-OM study (R01 DA050486) to assess if providing psycho-behavioral
interventions and medications for people with primary methamphetamine use disorder (MUD) and without
opioid use disorder (OUD) at methadone clinics is feasible and acceptable. In Vietnam and many US settings,
clinics providing medication for OUD (especially methadone clinics) are the only viable option for evidence-
based addiction treatment. Importantly, many of these clinics are at primary care level and therefore accessible
to people with primary MUD, who are in dire need for effective treatment. Furthermore, providers in methadone
clinics are capable of conducting psycho-behavioral interventions, which remain the first line of treatment for
MUD, and prescribing medications should these medications become available and approved by authorities. It
remains unknown, however, if methadone clinics could serve as treatment facilities for those with primary
MUD. In this Supplement to our STAR-OM study, we will 1) assess the feasibility and acceptability of three
recruitment strategies to enroll people with MUD and without OUD in MUD treatment at methadone clinics and
2) explore the feasibility and acceptability of providing psycho-behavioral interventions as well as challenges in
providing medications at methadone clinics for people with MUD and without OUD. In Aim 1, we will screen
600 people with primary MUD recruited through three strategies (peer outreach, snowballing and social media)
over 3 months to enroll 60 people with MUD and without OUD into the study interventions. Participants will be
screened at MMT clinics for meth use and readiness for MUD intervention. We will monitor recruitment rate for
each strategy to assess feasibility. We will assess acceptability through focus group discussions with people
who support recruitment (N=2 focus group with 12-16 participants), in-depth interviews with individuals eligible
for enrollment and agree or decline to participate in the study interventions (N=15, 5 per recruitment strategy).
In Aim 2, consenting participants will be randomized 1:1:1 into three arms of interventions over 12 weeks: (1)
contingency management only; (2) group-based Matrix plus contingency management; and (3) individual-
based Matrix plus contingency management. All participants will be required to provide urine samples
randomly once a week. We will monitor participation and retention rate in each treatment arm and completion
of urine drug screens to assess feasibility. We will assess acceptability through post-intervention in-depth
interviews with 15 participants, focus groups with methadone providers who deliver behavioral interventions (N
= 1 focus group with 6-8 participants), and in-depth interviews with policy makers at national and city levels
(N=5). In addition, we will ask participants in these interviews and focus groups about the challenges and
facilitators of providing medications for treatment of MUD at MMT clinics should they become available.
Findings from this Supplement will be used to prepare for a larger trial to assess effectiveness of implementing
psycho-behavioral interventions for people with primary MUD and without OUD at methadone clinics.

Public health relevance
Project narrative We propose to build upon the STAR-OM study (R01 DA050486) to assess the feasibility and acceptability of behavioral treatment and challenges of medication treatment for people with primary methamphetamine use disorder and without opioid use disorder at methadone clinics in Hanoi, Vietnam. Expanding treatment options at methadone clinics to provide evidence-based interventions to people with primary methamphetamine use disorder would be a cost-effective strategy to increase treatment coverage for this population. The study will provide preliminary data for prospectively assessing effectiveness and implementation barriers of the interventions.